The Lymphoma Epidemiology of Outcomes (LEO) Cohort Study (Diversity Supplement - Alexis Romero)

ABSTRACT
In 2020, an estimated 77,240 people in the US will be diagnosed with non-Hodgkin lymphoma (NHL), and 19,940
will die from this cancer. NHL incidence rates increased over the last half of the 20th century and only recently
stabilized. In parallel, NHL survival rates began improving in the mid-1990s with the advent of improved treatment
strategies, leading to the current 5-year survival rate of 74%. These trends have led to a growth in the number
of NHL survivors, estimated at over 757,000 in 2019. To address the unmet health needs of this patient
population, we established the Lymphoma Epidemiology of Outcomes (LEO) cohort study, which by June 2020
will have enrolled over 13,000 NHL patients and have <1% lost to follow-up. The LEO cohort supports multiple
grants and has generated novel and high impact findings on NHL prognosis and survivorship. To continue and
expand the key contributions of LEO, in this renewal we propose to: 1) Extend recruitment at all 8 LEO centers,
with a goal of recruiting 3400 newly diagnosed NHL patients focused on Hispanic (N=900), African American
(N=580), and Asian (N=200) participants (doubling the current sample size for these groups) and adolescent
and young adult (AYA) participants age 18-39 years (N=870; 87% increase), and non-metro and rural patients
of all ages and race/ethnicities (N=1,208, 72% increase), for a total cohort of 16,500 patients; 2) Review all
pathology diagnoses and maintain a NHL tumor bank that includes an H&E slide, formalin-fixed, paraffin-
embedded tissue samples in a tissue microarray, and extracted tumor DNA and RNA; 3) Collect a peripheral
blood sample and maintain a central biorepository of DNA, serum, plasma and buffy coat; 4) Annotate and
harmonize all cases with clinical, epidemiologic, pathology and treatment data, including development of new
informatics enhancements to capture clinical data from electronic health records, digital pathology images and
linkage to public databases to enhance data on environmental exposures and socioeconomic factors; 5)
Prospectively follow patients in the cohort to ascertain disease progression/relapse, retreatment, transformation,
second cancers, survival (including cause of death), updated exposures, patient- reported outcomes
(PROs), and other long-term health outcomes; and 6) Facilitate research projects that use this infrastructure,
promote interactions with NCI-supported clinical trials networks, patient advocacy groups, and other
collaborators. The goal of this Research Supplement is to gain a better understanding of how Hispanic
patients with lymphoma perceive lymphoma clinical trials, the barriers and/or facilitators to clinical trial
enrollment and various factors that influence ability or desire to participate in a clinical trial. We will
achieve these aims through close coordination of the participating centers. The LEO cohort is an exceptional
resource that supports a broad research agenda aimed at identifying novel clinical, epidemiologic, germline
genetic, tumor, and treatment factors that influence NHL prognosis and survivorship focusing on NCI research
priorities in AYA, minority, and rural populations.

Public health relevance
NARRATIVE NHL is the most common hematologic malignancy, and there are many unmet clinical and public health needs of this growing patient population. The goal of the LEO infrastructure grant is to support a cohort of over 16,000 non-Hodgkin lymphoma (NHL) patients in order to address broad and cutting-edge research that identifies clinical, epidemiologic (including lifestyle and other exposures), host genetic, tumor, and treatment factors, and the interaction among these factors, on short and long-term outcomes. The efforts of this Research Supplement are well aligned with the ultimate goal of identifying new approaches to improve the survival and well-being of NHL patients.